TRPV4 Regulates Mechanosensitive Macrophage Functions in Lung Injury

PROJECT SUMMARY/ABSTRACT
Overwhelming bacterial pneumonia injures and stiffens the lung leading to acute respiratory distress syndrome
(ARDS) that carries a mortality of up to 50%. Given many failed pharmacologic treatments, ARDS management
is supportive. ARDS is a consequence of endothelial and alveolar epithelial injury followed by recruitment and
accumulation of inflammatory cells in the injured alveolus. Macrophages are the key effector cells in the lung
injury process by phagocytizing invading pathogens and secreting cytokines. We have identified that the
mechanosensitive ion channel, transient receptor potential vanilloid 4 (TRPV4), protects the lung from injury in
an in vivo model of chronic Pseudomonas aeruginosa pneumonia through a novel mechanism of MAPK
molecular switching, from JNK to p38. However, the key intracellular signaling molecules that link TRPV4 to the
MAPK molecular switch and the precise cell phenotype/function that increases phagocytosis/bacterial clearance
and decreases lung injury are unknown. Uncovering novel mechanosensitive signaling mechanisms that control
macrophage function when the lung is injured/stiff will fulfill the unmet medical need to design therapies to treat
this devastating disease. This research proposal investigates the mechanism whereby TRPV4 adapts the host
defense to enhance the lung injury response to P. aeruginosa pneumonia. The long-term goal of our studies is
to deduce TRPV4-dependent intracellular signals in macrophages that protect and resolve pneumonia-
associated lung injury. Our preliminary data show that macrophage TRPV4 signals through specific intracellular
signaling molecules to alter the macrophage activation response in vitro. Therefore, we propose the novel
hypothesis: TRPV4 tailors the host response to protect the lung from injury after P. aeruginosa pneumonia
through macrophage intracellular signals. This hypothesis will be tested through three interrelated, but
independent specific aims: (1) to determine the mechanism whereby TRPV4 enhances macrophage
phagocytosis, (2) to determine the mechanism whereby TRPV4 limits pro-inflammatory cytokine
production, and (3) to compare the role of TRPV4 in alveolar vs interstitial macrophages in bacterial
clearance and infection-induced lung injury after P. aeruginosa pneumonia in mice. Our proposal is
innovative in concept as it is the first to implicate a matrix stiffness-sensing cation channel (TRPV4) and its
intracellular signaling molecules in bacterial pneumonia and associated lung tissue injury. The proposed
research is significant and relevant to the NIH’s mission as we aim to explore how TRPV4 in macrophages
integrates the infection and matrix mechanical signaling to protect the lung from injury. The pathways discovered
will identify novel therapeutic targets to treat infection-associated ARDS.

Public health relevance
PROJECT NARRATIVE Bacterial pneumonia leads to an uncontrolled response of the immune system that frequently causes lung injury/acute respiratory distress syndrome (ARDS). The molecular mechanism by which macrophages resolve infection-associated injury in the lung is not fully understood. Our research is aimed to support the novel concept that TRPV4 integrates the mechanical properties of the matrix and infectious signals to drive macrophage activation functions to protect the lung from injury.